Long-term skeletal effects of exercise during growth

DESCRIPTION (provided by applicant): This proposal will investigate the role of exercise (mechanical loading) during growth on lifelong skeletal health. Exercise is a commonly advocated intervention for osteoporosis as the skeleton is mechanosensitive and can adapt to loading. However, a disparity exists between when the skeleton is responsive to exercise (pre-puberty) and when it is prone to osteoporotic fracture (adulthood). This has raised the question of whether exercise-induced bone changes during growth persist into adulthood where they would be most advantageous in reducing fracture risk. Our strong preliminary data indicate that loading-induced structural changes in cortical bone are maintained long-term and contribute to lifelong enhancement of bone strength. The current proposal will explore this further in three translational animal studies by investigating: (1) the short- and long-term preservation of loading benefits at both cortical and trabecular sites;(2) the influence of an artificial menopause (induced via ovariectomy) on the preservation of loading effects, and;(3) potential mechanisms for the maintenance or loss of loading-induced changes. In each study, bone adaptation will be induced in the right forelimb or hindlimb of young rats using the ulna or tibial axial loading models, respectively. Left limbs will serve as nonloaded, internal controls. Animals will subsequently be detrained (restricted to cage activities) for 12, 18 or 92 wks, with ovariectomy being performed in some animals to induce an artificial menopause. Bone response to loading and detraining will be assessed using a combination of in vivo and ex vivo analyses. These studies will enhance the principal investigator's ability to perform independent research, strengthen his ties with collaborators, and expose graduate physical therapy students to meritorious translational research. PUBLIC HEALTH RELEVANCE: A commonly prescribed treatment for the increased risk for osteoporotic fracture associated with aging is exercise. However, the skeleton is most responsive to exercise around the time of puberty, and not when it is prone to osteoporotic fracture in later adulthood. This has raised the question of whether exercise-induced bone changes during growth persist into adulthood where they would be most advantageous in reducing bone fracture risk. This proposal will investigate the role of exercise during growth on long-term skeletal health.

Public health relevance
PROJECT NARRATIVE A commonly prescribed treatment for the increased risk for osteoporotic fracture associated with aging is exercise. However, the skeleton is most responsive to exercise around the time of puberty, and not when it is prone to osteoporotic fracture in later adulthood. This has raised the question of whether exercise-induced bone changes during growth persist into adulthood where they would be most advantageous in reducing bone fracture risk. This proposal will investigate the role of exercise during growth on long-term skeletal health.